HSR&D Senior Research Career Scientist Award

Project Summary/Abstract
As a VA Core Investigator at the HSR&D Center to Improve Veteran Involvement in Care and the
Evidence Synthesis Program Coordinating Center based at the Portland VA Healthcare System, my current
research activities include Scholarly Research, Training emerging scientists, and leading and participating in
Service to VA research and clinical programs. My current work is innovative and highly relevant for one of the
most dynamic and transformative periods for healthcare systems broadly, and for VA healthcare especially.
The overarching goal of my Scholarly Research activities is to understand and identify ways to improve
chronic disease management, including access, quality, and economic outcomes. I direct research on the
potential for care coordination models to improve chronic disease management for high risk/high need
Veterans and to offset any adverse effects of multi-system health care use across the VA and non-VA health
systems. My past research focused on Veterans with chronic kidney disease and cancer led to my current
focus on high risk/high need Veterans, including ongoing research on Veterans recovering from COVID-19
illness. Our HSR&D grant pending “Care Coordination and Outcomes for High Risk Patients: Building the
Evidence for Implementation”, seeks to identify the current care coordination processes and data resources
necessary to conduct a VA implementation study aimed at improving patient and provider experience and
health outcomes across VA and non-VA settings. The project also includes partnership with the VA Offices of
Community Care, Nursing, and Social Work and other VA offices. Proactive dissemination of my research
findings is done through briefings at stakeholder meetings and professional society meetings. I will continue to
produce peer reviewed publications of my own research and seek a new opportunity to edit a journal
supplement on care coordination as more evidence on implementation science grows and yields results.
My research Training activities aim to develop the next generation of VA health services researchers
with focus on skill development in methods, measurement, and applying health data resources. I am currently
mentoring four VA early career clinician scientists and one PhD postdoctoral fellow. As a graduate program
director in Health Management and Policy in my university role, I am and will continue to mentor MPH and PhD
candidates and make them aware of the opportunities the VA offers in HSR&D research careers. Further, with
faculty roles in Oregon State University (OSU) College of Public Health and Human Sciences, the OSU Center
for Genome Research and Biocomputing, and Oregon Health and Science University, together with a new
HSR&D Senior Research Career Scientist award, I will be uniquely positioned to develop a new training
program that draws on these multi-institutional relationships. My vision is to develop a new training program in
Data Science for Better Health, including data science to support care coordination process and outcome
measurement and analytics.
The goals of my research Service activities are to share my research expertise to inform clinical policy
and practice and to contribute to the VA research programs. I will continue involvement in the national VA
efforts to inform implementation of care coordination practice alongside our research. My contributions to
research programs will include continued support of our Veteran engagement efforts, and participation in peer
review activities and on advisory boards for critical VA research programs.
An award as a Senior Research Career Scientist would provide me with the opportunity to continue and
enrich these important research activities in conducting scholarly and impactful research, training the next
generation of scientists, and enhancing the visibility of VA research through leadership and service, and
ultimately benefiting the Veterans served by VA health systems.

Public health relevance
As an accomplished research health scientist and nurse, my research focuses on improving chronic disease management, including access to services, quality of care, and economic outcomes related to Veterans’ health and healthcare. Understanding the modifiable factors that improve health outcomes and healthcare continues to be highly relevant to the VA and to Veterans. My research contributions have positively impacted clinical practice, health care processes, and establishment of critical resources. I have contributed substantially to training the next generation of scientists. Most importantly, I have engaged patients and families in my research. A VA HSR&D Senior Research Career Scientist Award would enable me to enhance my research and scholarship, mentoring, service, and engagement contributions in addressing the potential for care coordination to improve Veterans’ health and healthcare across VA and community-based care.